2024 Biology of Host-Parasite Interactions Gordon Research Conference and Gordon Research Seminar

Project summary
The 2024 Gordon research Conference (GRC) on the Biology of Host-Parasite Interactions will focus on the
most recent molecular and translational advances in parasitic disease research. A wide range of human and
veterinary pathogens that cause disease will be emphasized, with the aim of bringing together scientists from all
over the globe to share and synthesize knowledge. The ultimate goal will be to improve the fundamental
understanding of these parasites and contribute to the design of future control and elimination efforts. A wide
range of topics will be covered at the conference, including: parasite metabolism and drug targets; immune
response to infection and parasite countermeasures; parasite genomics and epigenetics; differentiation and
developmental biology; biophysical/mechanical aspects of host-parasite interaction; and parasite manipulation
of host behavior. The breadth of this biennial meeting is unique in the field, and it is the only recurring meeting
that provides an opportunity for investigators working on a variety of protozoan and worm pathogens to interact
with immunologists and medicinal chemists. The meeting also provides academic scientists the opportunity to
compare approaches with investigators working within the pharmaceutical industry. The program has been
designed to cover this broad range of topics and we have commitments from top scientists in the field to attend
and speak. In addition, we will select short talks from the submitted abstracts, which will broaden diversity. There
will also be preceding Gordon Research Seminar (GRS), which offers a unique opportunity for postdocs and
graduate students to organize their own conference, to present their work through talks and posters, and to
exchange ideas at the forefront of research in a serene but stimulating atmosphere at the Salve Regina University
Campus, Newport RI. Speakers for the GRS will be selected from submitted abstracts reporting latest ground-
breaking findings. Students, post-docs and early career scientists are strongly encouraged to apply to both the
GRC and GRS. Special efforts are also being made to raise funds to provide support to individuals from endemic
countries.

Public health relevance
Project Narrative Parasitic infections inflict a tremendous toll on human health, both nationally and globally. The Gordon Research Conference on Host-Parasite Interactions is the most prominent venue for scientific exchange at the leading edge of modern parasitology research. The 2024 conference provides scientists with the opportunity to gain an overview of the entire field, to learn about the most recent and most exciting advances, and to discuss and set the national and global research agenda for the future.